Elucidating the processes mediating mosquito basement membrane repair and the implications on within-mosquito virus dynamics

Abstract/Project Summary:
Recent work has demonstrated that mosquito feeding biology, namely multiple blood feeding, can
greatly impact within-mosquito virus dissemination dynamics as well as time to transmission. When
mosquitoes feed, their midgut expands dramatically, the surrounding midgut basement membrane (BM)
becomes disordered, and constituent BM collagen IV triple helices become unfolded. If mosquitoes feed a
second time following an infectious blood meal, this transient damage is correlated with earlier virus escape
from the midgut and a weakening of the midgut escape barrier. Although some studies have addressed BM
development and repair in Drosophila, little is known from adult mosquitoes. Initial RT-qPCR studies suggest
that expression of the two forms of collagen IV, viking (vkg) and collagen at 25C (Cg25C), increase in the
midgut as BM damage decreases. Expression of secreted protein acidic and rich in cysteine (SPARC), a gene
important for BM collagen IV integration in Drosophila, was evident in the mosquito carcass (containing the fat
body). Other tissues and genes may also be important as earlier studies have noted expression of important
BM genes during development in the insect fat body, midguts, and hemocytes. In this application, the
spatiotemporal expression of BM genes and proteins following blood feeding will be investigated and
knockdown of genes of interest such as vkg, cg25C, and SPARC will reveal which genes are critical for BM
repair. Further, transgenic mosquito lines will be created with tissue-specific inducible expression of
fluorescently tagged genes involved in BM repair to identify the tissue of origin for proteins incorporated into
the repairing BM. From this, the relative importance of the different tissues that may be involved in BM repair
processes will be determined. Transgenic lines with constitutive expression of vkg and cg25C will be created to
determine if overexpression of collagen IV can affect BM repair and the timing of virus dissemination. This
investigation of mosquito midgut BM repair and the tissues involved will expand our knowledge of mosquito
biology, allow for the manipulation of these processes, and provide new targets for mosquito or pathogen
control measures.

Public health relevance
Project Narrative: When mosquitoes feed, the midgut expands rapidly leading to transient damage and disorder in the surrounding basement membrane (BM) layer that comprises the midgut escape barrier and prevents virus dissemination and subsequent transmission. Although the timing and extent of this damage impacts virus dynamics with more damage resulting in faster dissemination, the BM repair processes that control this window of escape are unstudied. In this application, I propose to study mosquito BM repair processes following blood feeding to expand our knowledge of the genes and tissues involved and to identify critical ways to alter this process for the purpose of future mosquito or pathogen control.